Engineering cell type-specific splicing regulation

PROJECT SUMMARY
Alternative splicing (AS) is a major driver of protein isoform diversity and is regulated in a highly cell
type-specific manner. A better understanding of the cell type-specific splicing code will not only provide novel
insights into the role of alternative splicing in disease and development but will also result in novel genetic tools
for perturbing and interrogating cell types of interest. Synthetic splicing constructs have been successfully used
to target activation of reporter and therapeutic genes to cancer cells carrying mutations in splice factors or to
make gene therapies conditional on a small molecular trigger. Existing examples highlight the potential of AS
as a programmable control mechanism but do not provide a clear path towards engineering splice regulatory
sequences that can be used to target gene expression to any desired cell type or state. Here, we propose to
combine synthetic biology with machine learning to generate highly cell type-specific splicing constructs.
Building on our earlier work, we will first quantify cell type-specific AS using splicing massively parallel reporter
assays (MPRAs). We will focus on exon skipping and intron retention because they are among the most
common forms of AS and can be highly cell type-specific. For each type of AS, we will create libraries with
hundreds of thousands or even millions of reporters with variation targeted to regions of interest. We will then
measure AS for these libraries in a panel of cell lines and cultured primary cells (Specific Aim 1). Next, we will
use these data to train machine learning models that can accurately predict AS isoform abundance from
reporter gene sequence. We will systematically compare different network architectures and approaches
including convolutional and recurrent neural networks. We will then combine models with sequence design
approaches previously developed in the lab to generate synthetic sequences with enhanced target cell
specificity. We aim to show that we can generate reporter constructs that are specific to any cell type in our
panel. We will validate predictions experimentally and use resulting data to iteratively improve model
predictions (Specific Aim 2). Finally, we will generalize our approach to an experimental setting that more
accurately reflects the diversity and complexity of cell types encountered in multi-cellular biological systems.
Specifically, we will perform splicing MPRAs in organotypic developing rat brain slice culture. We will optimize
conditions for library delivery to slice culture and we will similarly optimize approaches for reading out splicing
MPRAs at the single cell level. We will combine the resulting data with the generative models from Specific Aim
1 to design reporter constructs that precisely target protein expression to cell types of interest (Specific Aim
3). We believe that this work will result in novel genetic tools for biology research and provide a path towards
gene therapies with increased specificity and reduced side effects.

Public health relevance
PROJECT NARRATIVE This research seeks to develop predictive and cell type-specific models of alternative splicing by learning from millions of synthetic splicing constructs, characterized across a large number of cell types. Models will be combined with molecular design algorithms to engineer splicing constructs that target protein production to cells of interest thus providing a path toward increasing the specificity of future gene therapies.